Animal Models Core

Abstract
The Animal Models Core of The Scripps Research Institute Alcohol Research Center (TSRI-­ARC) will provide
a variety of behavioral and bioanalytical services to meet the specific needs of the Center at large. The first
goal of the Animal Models Core is to provide animals that are dependent or have a history of dependence on
alcohol after chronic intermittent ethanol vapor exposure (CIE model) to TSRI-­ARC and Center at Large
investigators (Specific Aim 1). The core will also supervise all changes in equipment, procedures, and any
refinement of the current animal models to ensure that standardized procedures are used across all
laboratories. The second goal of the Animal Models Core is to perform biochemical measurements, such as
blood alcohol, cortisol/corticosterone, and estrous cycle phase determinations in support of all ARC-­related
projects and establish an alcohol biobank that will provide tissues to NIH-­funded investigators and academic or
non-­profit research institutions (Specific Aim 2). The last goal of the Animal Models Core is to provide
preclinical testing to all TSRI-­ARC PIs and determine the dose range of efficacy of novel compounds to be
tested in the clinical component of the TSRI-­ARC (Specific Aim 3). The Animal Models Core will enable ARC
investigators to enrich the interpretational power of their experiments through standardized models,
standardized biological analyses, and preclinical testing capabilities.